FASEB's "The Nutrient Sensing and Metabolic Signaling Conference"

Principal Investigator/Program Director (Last, first, middle): Kimball, Scot R. The specific aims of this FASEB science research conference are to meet to 1) present and discuss the most current work on fundamental aspects of nutrient sensing and signal transduction events in the modulation of health and disease; 2) bring together physician- scientists and research scientists in diverse research fields to promote interdisciplinary discussion and collaboration; and 3) encourage the attendance and participation of new and young scientists such as junior faculty, graduate students, and postdoctoral fellows, with special emphasis on women and under-represented minorities. Thirty-four senior investigators and up to 8 junior investigators will serve as invited speakers. Poster sessions will permit all participants to contribute, and an additional poster competition for trainees will provide special attention and recognition for their research efforts. Dr. Laurie Goodyear, PhD, an international expert in exercise and nutrient and metabolic signaling, will deliver a keynote address on how maternal and paternal exercise and diet alter offspring metabolic health, followed by eight sessions that broadly address current issues in nutrition and metabolism in diabetes, neonates, and the elderly as well as a session on the interaction of nutrients and exercise in maintenance of muscle metabolic homeostasis. The total number of participants will be limited to 200 to encourage interaction and increase the opportunity for junior attendees to meet and discuss research with senior scientists. The five-day meeting will be held August 9-14, 2020 in Nova Scotia, Canada.

Public health relevance
Principal Investigator/Program Director (Last, first, middle): Kimball, Scot R. Project Narrative This application seeks funding to support the participation of junior investigators at the 2020 FASEB science research conference on “Nutrient Sensing and Metabolic Signaling”, held in Nova Scotia, Canada on August 9-14, 2020. The main objective is to promote interdisciplinary discussion and collaboration among junior and senior physician-scientists and research scientists in fields related to obesity, diabetes, nutrition, and exercise across the life span.